Development and validation of a computable knowledge framework for genomic medicine

Project Summary/Abstract
Genomic medicine is the discipline of interpreting genomic information about an individual as part of their
clinical care, for diagnosis, prognosis, or therapeutic decision-making. Integral to the practice of genome
interpretation is the collection of multiple lines of evidence from knowledgebases to support or refute the
clinical significance of evaluated variants. Modern clinical variant knowledgebases maintain literature and
variant coverage that is mostly non-overlapping. This diversity of content causes a known problem in genome
interpretation: analysts tasked with assembling a clinical variant report choose to spend considerable time
navigating multiple resources and collating evidence, or risk missing critical information by selectively
evaluating fewer resources. The resulting effort needed for an analyst to clinically interpret a variant list is
known as the interpretation bottleneck, for its rate-limiting role in the clinical evaluation of patient genomes.
Data integrators from public and private genomic medicine organizations work to alleviate this bottleneck by
developing integrative clinical interpretation applications for use by genome analysts. As new knowledgebases
are created, each of these public and private data integrators is left with the task of designing and maintaining
another interface for each new resource, leading to combinatorial growth of data harmonization effort across
the entire system. This approach is not scalable.
This project will enable a transition to a scalable, interoperable, and federated genomic data ecosystem from
the data integrators and knowledgebases already in existence today. To build an interoperable network of
knowledgebases will require development and validation of a computable knowledge framework for genomic
medicine. The framework will require the drafting of modern genomic knowledge standards, and development
of the tools and services needed to support the implementation of those standards. These objectives will be
carried out through coordination of several research activities with the Variant Interpretation for Cancer
Consortium, ClinGen, and the Global Alliance for Genomics and Health. Research will involve
conceptualization of genomic knowledge as precise computable concepts, designing schema for those
concepts, developing framework support tools, and building intuitive user applications to leverage these
advances.
As a result of this research, new knowledgebases implementing this framework become immediately
accessible to existing applications, while new applications and workflows implementing this framework are
immediately able to leverage a wide breadth of data sources. In addition to these immediate benefits, the
creation of a standardized, federated knowledge network reduces barriers for developing new products,
spurring innovation towards novel applications for research, education, and clinical decision support tools.

Public health relevance
Project Narrative Currently, it is very time-consuming and costly to search multiple resources to clinically evaluate genomic variants. This project will create the computational concepts and tools needed to quickly and precisely search across many resources, dramatically reducing the time and cost of clinical variant evaluation while improving our ability to find relevant clinical evidence.